IMMUNOPATHOGENESIS OF BERYLLIUM DISEASE

The major goal of this proposal is to increase our understanding of the immunopathogenesis of chronic beryllium disease (cbd). Specifically, we are testing the central hypothesis that a beryllium-specific T cell response is required for the development of chronic beryllium disease, and that only a subset of these T cells are involved in the pathologic process.